Using National Sales Data to Understand the Influence of Menu Labeling Policy

Project Summary/Abstract
Obesity is a pervasive health problem in the United States, and poor diet is now the largest contributor to
premature mortality in addition to causing cardiovascular disease, cancer and diabetes. Although a number of
policies have been developed to address obesity by changing the environment in which food is purchased,
research is needed to understand the impact these policies might have on food purchasing and obesity. Menu
labeling is one such policy, requiring chain establishments to disclose the caloric value of menu items in text
alongside each menu item so consumers can make more informed choices. These policies began in 2008 and
were implemented nationwide under federal law in 2018. Prior studies of menu labeling are valuable yet lack a
key feature needed to better understand the impact of labeling: large scale data on a vast number of purchases,
which would allow for the estimation of small but meaningful cumulative effects (i.e., effects that produce
population-level dietary improvements). We address this problem by using data provided from Taco Bell, a
chain that has over 7,000 stores in the U.S., with over 5 billion transactions since 2007. The company has given
us full access to receipt-level data, meaning we can identify the exact items (and calories) ordered for each
purchase. These data and the staggered rollout of menu labeling policies across the nation from 2008 – 2018
will allow us to use a quasi-experimental design to demonstrate the impact of menu labeling on items and
calories purchased in an incredibly well-powered and nuanced manner. We are unaware of any other
examination of menu labeling that leverages such large-scale sales data, including at a national level.
Our specific aims are:
• Aim 1: Determine the impact of calorie labeling on calories purchased by Taco Bell consumers.
• Aim 2: Determine the extent to which the impact of labeling differs by characteristics of the community,
including a) demographics of the community (income and race/ethnicity), and b) urbanicity of the
restaurant location.
• Aim 3: Determine the extent to which the impact of labeling differs by characteristics of the purchase,
including a) time of day, b) weekend or weekday, and c) drive through or ordered in the restaurant.

Public health relevance
Project Narrative Obesity is one of the most complex public health challenges facing the United States. This proposal utilizes a large and comprehensive set of data, all purchases made at Taco Bell from 2007 - 2023, to examine the impact of menu labeling policy on calories purchased.